EFFECTS OF TWO METHODS OF SPINAL IMMOBILIZATION ON RESPITORY EFFORT

The purpose of this study is to determine the effect of two different types of spinal immobilizatiion devices on respiratory effort in the older adult, aged 65-75.